Alzheimer's Disease Research Center

ADMINISTRATIVE CORE SUMMARY
Both the general and thematic goals of this application for a renewed P30 at Columbia University were
conceived with the directives of the FOA (RFA-AG-24-001) and the aspirational objectives of the Congressional
National Alzheimer’s Project Act (NAPA) in mind.
Building off our prior P50 and our current P30, our general goals include maintaining a research infrastructure
on Alzheimer’s disease and related dementias (ADRD), fostering interdisciplinary collaborations across many
departments, providing a rich training environment, supporting outreach and patient recruitment, and training the
next generations of ADRD scientists. Additionally, encompassed within our general goals is a continuation of
our participation in clinical trials and national coordinated efforts, our working with the national network of other
Centers, and our interactions with other organizations in their advocacy efforts.
Embedded within these general aims are the Center’s thematic goals. As fully articulated in the Overall
component, but also briefly discussed in the Research Strategy of this Core, our thematic goals are anchored in
our current theme: To better understand how AD’s pathogenic biological pathways (i.e., the endosomal trafficking
pathway and the immune response pathway) interact with AD’s canonical pathologies (amyloid pathology, tau
pathology, neurodegeneration). As detailed in the Overall component and below, in this proposed P30 renewal
we plan on expanding this ‘pathways-pathologies’ relationship to include its link to ADRD at-risk populations and
clinical trials.
The Administrative Core will act as the executive governing body of the Center that, with the guidance of its
various committees, will provide the vision and leadership necessary to achieve the Center’s general and
thematic goals. The Core will implement this vision by exercising managerial oversight and scientific leadership
over all aspects of the Center, which includes ensuring the highest standards of scientific and bioethical conduct,
and a judicious use of resources and funds.